Defining the functional and spatial properties of tumor-specific tumor-infiltrating CD8 T cells

Project Summary/Abstract
Successful anti-tumor immune response requires coordination between the arms of immunity against multiple
tumor antigens, as shown through studies of animal models and human immune responses. Key to cancer cell
elimination are T lymphocytes, and in particular cytotoxic CD8 T cells, which serve to recognize antigens
presented on tumor cells on an HLA class I molecule, through their T cell receptors (TCRs). Correspondingly,
recent advances in immunotherapy geared at boosting T cell cytotoxicity through immune checkpoint blockade
(ICB) have transformed the treatment landscape for many patients suffering from solid tumors. However, in
melanoma, ICB induces an objective response only in around 40% of patients. The limited efficacy of ICB has
been previously linked to the presence of dysfunctional T cells within the tumor microenvironment (TME),
persisting in a state of terminal exhaustion. There is thus a pressing need to better understand the determinants
of T cell responses against tumors. To investigate these mechanisms, our lab has extensively characterized the
landscape of anti-tumor T cells infiltrating melanoma and RCC biopsies, establishing that tumor-specific T cells
are found overwhelmingly in the exhausted T cell compartment. Still, the required antigenic diversity and spatial
interactions of such tumor-specific T cells determining anti-tumor response in vivo is poorly understood.
Additionally, the relative importance of antigen class, particularly neoantigens and tumor-associated antigens
(TAAs), to effective anti-tumor T cell responses is incompletely understood. In Specific Aim 1, I thus propose to
generate patient-derived xenograft (PDX) murine models of 3 melanoma patient tumors, to test the required
diversity of TCRs chosen from tumor-infiltrating T cells using markers associated with tumor specificity to exert
immune pressure on a heterogeneous tumor like melanoma. By infusing T cells transduced with varying numbers
of putative patient tumor-specific TCRs, or control non-tumor-specific TCRs, I will be able to assess the diversity
of TCRs required to control tumor growth. Further, in Specific Aim 2, I will investigate the role of antigen class
in tumor control using one of these melanoma PDX models, in combination with a cell-barcoding system, to track
the relative immune-induced selection on the tumor of TCRs specific against either neoantigens or TAAs in vivo.
Finally, in Specific Aim 3, I will utilize spatial sequencing techniques to study the localization of CD8 T cells first
within my T cell-challenged PDX models, to characterize tumor-intrinsic immunosuppressive interactions and
infiltration of T cells in my PDX models. I will then investigate the interactions and associated phenotypes of
tumor-specific T cells in the native TME of patient melanoma biopsies from recurrent tumors. Achievement of
these aims will lead to a pipeline that could isolate putative tumor-specific T cells through cellular markers to
identify their TCRs, followed by re-expression of these putative tumor-antigen-specific TCRs into non-exhausted
T cells primed in an optimal cell state for anti-tumor cytotoxicity as an autologous adoptive cellular therapy.

Public health relevance
Project Narrative Anti-tumor immune responses and response to immunotherapy rely on direct recognition by cytotoxic CD8 T cells of antigens presented on the surface of tumor cells. Tumors like melanoma suppress native immune response through induction of T cell dysfunction and exhaustion, but the direct interactions between tumor- specific CD8 T cells and cells in the tumor leading to dysfunction are incompletely understood. Investigation of the anti-tumor T cell specificities required for tumor control, and the intratumoral interactions of tumor-specific CD8 T cells in melanoma, will contribute to a better understanding of the mechanisms driving anti-tumor T cell responses and pave the way for future TCR-based therapeutic approaches.